Multimodal Multi-Electrode Array (MEA) for Probing Tooth Root Organoid Maturation and Sensory Innervation

PROJECT SUMMARY
In the United States, the average number of teeth in adults decreases by 35% by the age of 65. Missing teeth
are replaced by artificial dental implants, which, among other drawbacks, do not provide sensory cues during
mastication due to the absence of nerve innervation. The Syed-Picard lab at the University of Pittsburgh has
developed a self-assembling tooth root organoid with remarkable differentiation into distinct spatial layers using
postnatal stem cells derived from human patients during wisdom tooth extraction. Nerve innervation of the tooth
root occurs in a precise spatiotemporal manner. Here, we aim to evaluate proper innervation of the tooth root
organoid by investigating the spatiotemporal dynamics of neurotrophic factors in the organoid and the nerve
innervation itself over the course of the organoid’s 14-day maturation period. Moreover, we evaluate the
functionality of the innervated sensory nerves through electrophysiology. Microelectrode arrays (MEAs) are used
extensively in vitro and in vivo to record and modulate neural activities and are being explored as a powerful tool
for biochemical sensing with high spatial and temporal resolution. Aptamers have been applied as bio-recognition
elements in customizable biosensor MEAs, but their poor stability in biological environments can result in a very
short sensor lifetime. Moreover, the standard method for attaching aptamers on MEAs does not allow for site-
specificity, preventing the design of multi-modal sensors that can sense multiple analytes and perform
electrophysiology. In this research, we aim to develop a highly stable aptamer functionalized MEA for multimodal
interrogation of the organoid. In Aim 1, I will develop a highly customizable and stable electrochemical biosensor
through electrodeposition of porous nanoparticles functionalized with the aptamers of choice. The MEA will be
custom-designed and fabricated to interface with the multiple layers of the organoid, sense multiple analytes,
and stimulate neurons. In Aim 2, I will implant my aptamer functionalized MEAs for BDNF and NGF detection
and track their spatiotemporal expression over the 14-day maturation period. In Aim 3, I will co-culture sensory
neurons with the organoids to stimulate and track neural firing and correlate it spatiotemporally with BDNF and
NGF expression as sensory innervation matures. Nociceptive stimuli will be applied to the mature organoids in
the form of capsaicin, acid, and heat, and the neuronal responses will be measured. I will receive training from
Dr. Tracy Cui on neurochemical sensors and neural recording and Dr. Fatima Syed-Picard on stem-cell biology,
organoids, and neuroregulatory processes directing innervation during tooth development. The University of
Pittsburgh is a world-class neural engineering research center and highly ranked dental and craniofacial research
institution. Drs. Cui and Syed-Picard have an established collaborative relationship and will provide the optimal
environment for this project.

Public health relevance
PROJECT NARRATIVE Organoid models, particularly those made from post-natal patient-derived tissue, represent an important step in the realization of personalized medicine. I am proposing to develop a multimodal microelectrode array (MEA) that can stably sense spatiotemporal patterning of neurotrophic factors and probe sensory neuron innervation and function in a tooth root organoid made from post-natal STEM cells. Moreover, the multi-modal MEA developed in this study can be translated to many additional studies where the study of multiple biochemical analytes and neural activity over chronic time scales is desired.